Clinical Pharmacology (CP)

Project Summary/Abstract: Clinical Pharmacology
The Clinical Pharmacology (CP) Shared Resource is in its 24th year of operation and supports Norris Cotton
Cancer Center (NCCC) investigators in the design, performance, data analysis, and interpretation of
pharmacology objectives in preclinical (in vivo and ex vivo), clinical and epidemiological studies at the lowest
cost and highest value possible. The major CP services are in four domains: (1a) Development of novel
analyte assays (when such assays are only available as research methods) increasingly using either liquid-
chromatography mass spectrometry (LC-MS/MS) or high performance liquid chromatography (HPLC) with
ultra-violet and/or fluorescence detection methods; (1b) Performance of analyte-concentration measurements
in biospecimens from preclinical and clinical oncology studies using these validated bioanalytical assays; (2a)
Expert consultation regarding study design and pharmacokinetic (PK) and pharmacodynamic (PD) hypothesis-
development and testing in preclinical and clinical cancer studies; (2b) PK and PD data analysis and PK-PD
modeling from pre-clinical and clinical studies; (3) Central processing for biospecimens (e.g., cells, tumor
tissue, plasma, saliva, urine, DNA) obtained as part of approved clinical and epidemiological protocols;
services that include: sample logging, processing (including processing peripheral blood mononuclear cells),
aliquoting, storage and sample distribution when necessary; and (4) Research pharmacy services for cancer
therapeutic clinical studies with both commercially available drugs and drugs under an investigational new drug
application. CP is directed by Dr. Lionel D. Lewis, who has established expertise in the clinical performance of
PK and PD for early phase clinical studies of investigational oncology drug or drug/drug combinations. Other
staff includes a junior faculty pharmacologist with bioanalytical and molecular pharmacology expertise, a
research assistant-lab manager with expanding bioanalytical and biospecimen stewardship expertise, and a
research pharmacist with expertise in oncologic and investigational drug pharmacy. During the period 1/1/15 to
11/30/18, 15 NCCC Members from all 4 NCCC Programs utilized the CP Shared Resource, 9 of whom are
current Members in 3 Programs (CPS [2], CBT [6], and ICI [1]). NCCC Funded Member Use represented 93%
of Total Use (42 Projects), and we are requesting 78% of the CP Total Operating Budget from CCSG support.